Non-Pharmacologic Approach to Rhythm Control and Rate Control of Postoperative Atrial Fibrillation.

Project Summary/Abstract
Postoperative atrial fibrillation (POAF) is the most common complication following open heart surgery, with
an incidence of up to 50%. It is associated with significant morbidity, including stroke, heart failure, and
hemodynamic compromise. For the treatment of POAF, there are two strategies, either rhythm control (restoring
and maintaining sinus rhythm) or rate control (controlling ventricular rate). Medications used to maintain sinus
rhythm are largely ineffective, and those used to control ventricular rates during POAF often cause hypotension.
Therefore, to improve management of POAF, a non-pharmacologic treatment strategy could be implemented.
The current non-pharmacologic treatment of POAF is direct current (DC) cardioversion, which is often needed
to treat patients who are hemodynamically unstable. However, DC cardioversion is often ineffective, as the POAF
usually returns quickly. Although a recent clinical trial showed that rhythm control and rate control are equivalent
in terms of mortality, length of hospital stay, and complication rates, a longer duration of POAF is associated with
worsened long-term survival and risk of AF recurrence. The lack of satisfactory treatment of POAF is due in large
part to our insufficient understanding of its mechanism. In our canine sterile pericarditis model (an experimental
counterpart to POAF), we demonstrated that activation and proliferation of epicardial inflammation occurring in
the atria produces a loss of epicardial myocytes and an altered distribution of connexins 40 and 43. These
changes are associated with non-uniform slowing of conduction, thus creating the vulnerable substrate for the
spontaneous initiation and maintenance of POAF. Our epicardial mapping studies in this model demonstrated
that POAF is caused by a reentrant circuit circulating around pulmonary veins. Our recent study in patients with
POAF after open heart surgery showed that atrial electrograms during POAF recorded from selected left atrial
(LA) sites demonstrated regular cycle lengths, consistent with a LA reentrant circuit similar to our canine model.
Therefore, like other reentrant arrhythmias, the POAF rhythm has the potential to be pace terminated (rhythm
control). When there is another mechanism maintaining POAF, a rate control approach using fat pad stimulation
could be used to control the ventricular rate during POAF. The central hypothesis of our proposal is that when
POAF is due to a reentrant mechanism, it can be terminated by a non-pharmacologic rhythm control strategy
(overdrive pacing); when POAF is due to other mechanisms, it can be managed by a non-pharmacologic rate
control approach (atrioventricular node fat pad stimulation). The hypothesis to be tested has three specific aims:
Aim 1 is to develop non-pharmacologic approaches in our canine model. Aim 2 is to test the hypothesis that
POAF is due to an anatomical reentrant circuit in patients after open heart surgery. Using entrainment pacing
during POAF, we will verify the existence of a reentrant circuit. Aim 3 is to test the hypothesis that POAF can be
managed by a patient-specific non-pharmacologic approach. Insights from our proposed studies will change the
paradigm for the treatment of POAF, and contribute to improved clinical outcomes in these patients.

Public health relevance
Project Narrative Postoperative atrial fibrillation (POAF) is the commonest complication after open heart surgery and is a growing clinical problem. Also, POAF is no longer considered a transient one-time event as a longer duration of POAF is associated with worsened long-term survival and risk of AF recurrence. The studies in this research proposal will change the paradigm for the treatment of POAF following open heart surgery, and contribute significantly to the management of this common complication.